Aldh2 and mitochondrial homeostasis in esophageal pathobiology

PROJECT SUMMARY
Esophageal squamous cell carcinoma (ESCC) is the deadliest of all human squamous cell carcinomas with
alcohol as a major risk factor. The role of alcohol (ethanol) in the esophageal epithelial cell injury and ESCC
pathobiology remains unknown. Ethanol metabolism produces acetaldehyde, a major human carcinogen.
Amongst the target organs alcohol drinking may cause diseases, esophagus is unique because it is directly
exposed to high concentrations of EtOH and acetaldehyde. Alcohol detoxification involves clearance of
acetaldehyde via aldehyde dehydrogenase 2 (Aldh2), the mitochondrial enzyme which breaks down aldehydes.
Aldh2 dysfunction increases cancer risk in individuals with polymorphic Aldh2 mutation (Aldh2E487K). In Aldh2-/-
and Aldh2E487K mutant mice and Aldh2-depleted human esophageal epithelial cells, alcohol induces
mitochondrial damage and oxidative stress with increased DNA adducts formation and DNA damage,
suggesting that mitochondrial dysfunction and reactive oxygen species (ROS) may contribute to genetic
instability in Aldh2 dysfunctional esophageal epithelial cells. Alcohol-induced oxidative stress is alleviated by
autophagy, a cytoprotective mechanism which removes damaged cellular components including dysfunctional
mitochondria. Moreover, alcohol stimulates ESCC tumor growth with increased tumor-initiating cells displaying
high autophagy and high CD44 expression (CD44H). The long-term goal is to identify esophageal mucosal
defense mechanisms that can be manipulated for prevention or therapy of ESCC. The overall objective in this
proposal is to clarify how alcohol affects esophageal epithelial cells with Aldh2 dysfunction. This proposal
utilizes genetically engineered mouse models, patients' biopsies, human cell lines with altered Aldh2 status via
the CRISPR/Cas9-approach, xenograft serial transplantation assays and a novel 3D esophageal organoid
system with ethanol exposure and pharmacological interventions as a comprehensive platform to define the
mechanistic and functional role of Aldh2 in epithelial response to alcohol exposure. The central hypothesis is
that Aldh2 limits alcohol-induced mitochondrial dysfunction, suppressing oxidative stress and ESCC tumor
initiation and growth. This hypothesis has been formulated on the basis of strong preliminary data produced in
the applicant's laboratory and will be tested by pursuing the following three interrelated Specific Aims: (1) To
clarify how mitochondrial Aldh2 limits alcohol-induced esophageal epithelial cell injury; (2) To define how
autophagy reduces alcohol-induced mitochondrial damage and oxidative stress; (3) To determine how Aldh2
influences alcohol-induced esophageal neoplastic characteristics. These innovative studies will reveal novel
insight into the role of dysfunctional Aldh2 in alcohol-induced oxidative stress and esophageal epithelial cell
injury as well as autophagy-mediated cytoprotection in the pathogenesis of ESCC and other alcoholic diseases,
both benign and malignant.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because a detailed understanding of the role of Aldh2 and alcohol-induced epithelial cell injury will fundamentally advance the fields of alcohol-related diseases, both benign and malignant. The proposed model systems and findings will provide a platform for new avenues of translational applications related to esophageal squamous cell carcinoma and other alcohol-induced human pathologies. Thus, the proposed research is relevant to the NIH's mission that pertains to developing fundamental knowledge that will help to reduce the burden of human diseases.